The role of the integrated stress response in brown adipose tissue-mediated metabolic adaptations

This project seeks to understand the role of the integrated stress response (ISR) in brown adipose tissue
(BAT) for systemic metabolic homeostasis. The studies proposed herein have the potential of uncovering a
novel pathway to amplify thermogenic activation of BAT and to induce the BAT secretome, that might be
independent of β3-adrenergic activation, and might be leveraged to combat obesity and its comorbidities.
BAT plays a critical role in maintaining core body temperature through adaptive thermogenesis, and can affect
adiposity by regulating key pathways in energy homeostasis. Accordingly, strategies designed to activate
BAT, as well as to promote browning of white adipose tissue (WAT), could be attractive for combating obesity
and associated diseases, such as diabetes and cardiovascular disease (CVD). Recent studies demonstrated
that the ISR is activated in BAT in response to acute cold exposure, which correlated with induction of the
unfolded protein response (UPR) and secretion of batokines known to exert protective effects on systemic
metabolism, such as fibroblast growth factor 21 (FGF21) and growth and differentiation factor 15 (GDF15).
We have generated preliminary data confirming these findings. In addition, we observed similar inductions of
the UPR and the ISR in mice with BAT-specific deletion of the mitochondrial protein Optic atrophy 1 (OPA1).
Interestingly, these mice had improved metabolic fitness and were better able to adapt to cold. Although
studies suggest that BAT-derived FGF21 plays a negligible role on the systemic metabolic adaptations to cold
exposure, the contribution of BAT-derived GDF15 on adaptive thermogenesis and on systemic metabolic
homeostasis is incompletely understood. Therefore, we hypothesized that cold exposure and mitochondrial
stress lead to the induction of the ISR and its master regulator activating transcription factor 4 (ATF4) in BAT,
via the activation of the UPR kinase protein kinase R (PKR)-like endoplasmic reticulum kinase (PERK) to
induce BAT secretion of GDF15, thereby improving systemic metabolic homeostasis. Extensive examination
of the ISR in BAT will shed light on BAT physiology and adaptation to stress and may uncover novel
therapeutic targets for the treatment of obesity, diabetes and CVD. Aim 1 of this proposal will investigate the
requirement of PERK for ISR and ATF4 activation in BAT in response to cold and mitochondrial stress. Aim
2 will determine whether ATF4 is required and sufficient for GDF15 induction and for proper adaptive
thermogenesis. Aim 3 will determine whether GDF15 is required to mediate the systemic metabolic
adaptations following cold exposure and mitochondrial stress in BAT, and whether it mediates its effects
through central activation of its receptor glial-derived neurotrophic factor receptor alpha-like (GFRAL).
Generation of novel genetic mouse models will reveal the molecular mechanisms underlying ISR activation
and the physiological roles of ATF4 and GDF15 in BAT, which may inform novel therapeutic strategies to
combat obesity and its comorbidities.

Public health relevance
Cold exposure and mitochondrial stress induce the integrated stress response (ISR) in brown adipose tissue (BAT), resulting in the activation of the activating transcription factor 4 (ATF4). This proposal will elucidate the role of the unfolded protein response (UPR) kinase PERK on ATF4 activation, and will determine whether ATF4 is required and sufficient for the systemic metabolic adaptations to cold exposure and mitochondrial stress, via the secretion of growth and differentiation factor 15 (GDF15), as a batokine.